Discovery of Glutaryl-CoA Dehydrogenase inhibitors for melanoma and pancreatic cancer

PROJECT SUMMARY
Melanoma is an extremely aggressive cancer with high mortality. Its phenotypic plasticity and heterogeneity
enable it to adapt to diverse physiological settings and defeat treatment approaches. Targeted therapies and
check point inhibitors became available in the past decade; however, these drugs work in only a subset of
patients and drug resistance eventually emerges, even in initial responders. Therefore, new targets and clinical
approaches for melanoma are an unmet medical need. We identified glutaryl-CoA dehydrogenase (GCDH) as
one such target. GCDH expression correlates with aggressive cancers and low survival in melanoma patients.
Our data demonstrates that GCDH knockdown results in apoptotic cell death in melanoma cells. Melanomas
seem uniquely sensitive to toxic glutarate metabolites resulting from GCDH deficiencies, since suppression of
the Dehydrogenase E1 and Transketolase Domain Containing 1 (DHTKD1) enzyme, catalyzing the preceding
reaction in the catabolic pathway and converting 2-oxoadipate to glutaryl-CoA, rescues melanoma cells from
apoptosis. Pancreatic cancer cells, but not other cancers nor normal cells, share this overreliance on GCDH and
undergo apoptosis upon GCDH knockdown. We hypothesize that small-molecules interferring with GCDH will
result in the obliteration of melanoma cells through apoptosis. We propose to identify chemical probes of GCDH
to further validate the enzyme as a molecular target for melanoma. In a pilot screen, we established and validated
all of the assays proposed herein. We will perform large-scale HTS, hit confirmation and optimization, and
validate the identified hits in a panel of diverse cell lines for melanoma and other cancers. Compounds identified
will provide desirable pharmacological tools to study the pathophysiology of GCDH in melanoma and other
cancers, and the molecular mechanisms of lysine metabolism liability in melanoma, as well as provide potential
starting points for future therapeutic treatments. This 4-year project will pursue the following Specific Aims,
consistent with the expectations in PAR-20-271: AIM 1 Generate GCDH protein, optimize conditions and perform
screening to identify compounds targeting GCDH. Optimize tertiary assays for hit validation. Primary assays will
target binding activity and inhibition, and tertiary assays will monitor cellular target engagement and protein level.
AIM 2 Perform hit selection, confirmation and profiling using a panel of secondary assays. Functional hit profiles
will be established using inhibition assays for a representative of acyl-CoA dehydrogenases and mechanism of
action studies by using protein thermal shift with substrate analogs and enzyme kinetic studies to establish
competition profiles with the substrates. AIM 3 Perform hit validation and scaffold prioritization using biochemical
and cellular assays. GCDH target engagement will be confirmed in an in-cell protein stability assay. Effects on
cellular protein levels will be evaluated using endogenous-tagged GCDH in melanoma cells. Best scaffolds will
be validated in cellular assays to monitor apoptosis, cell viability, and specificity towards melanoma and
pancreatic cancer.

Public health relevance
PROJECT NARRATIVE Melanoma is the most aggressive form of cancer, which is characterized by rapid spread from skin to vital organs such as liver, kidneys, heart and brain, and while it represents only about 4% of skin cancer cases, it accounts for 75% of all skin cancer deaths. A number of new therapies became available within past decade, however, a significant portion of patients don't respond to the treatments or develop resistance over time. The investigators and collaborators of this proposal identified an enzyme (GCDH), which is associated with these aggressive and resistant melanomas, as well as pancreatic cancers, and, when inhibited, promotes cancer cell death, which the team will exploit in the proposed work to identify and validate chemical compounds that inhibit GCDH and establish potential of the enzyme as novel promising therapeutic target for melanoma and pancreatic cancer.